Phase II Clinical Trial to Evaluate a Vaccine Candidate for Gonococcal Infection

This IAA seeks to support the protocol development, clinical trial implementation, close out and analysis of a phase 2 clinical trial to evaluate the efficacy of a vaccine candidate in preventing Neisseria gonorrhoeae (Ng) infection.